Alaska INBRE 4 One Health

Alaska INBRE 4 - OVERALL PROJECT SUMMARY
Since 2014, AK INBRE 3 has enhanced the research capacity of developing faculty and investigators
throughout its network of University of Alaska universities by awarding pilot research grants, providing salaries
to technicians, training of post-doctoral scientists and graduate and undergraduate students, and supporting
travel, science advising, and equipment purchases. AK INBRE 3 provided support for bioinformatics and
biostatistical analyses to network investigators through building local capacity in genomics, distributing service
awards for DNA sequencing, data analysis, and networking with national bioinformatics centers, and
supporting three summer workshops for advancing lab and computational skills. This support has been
instrumental in increasing the number of independent NIH R-series awards to investigators in the network from
7 to 17 and total annual NIH funding to Alaska from $9.5 to $21.2M. Four developing faculty transitioned to
independent status. To enhance translational and clinical research and strengthen its focus on Alaska Native
health research as part of its research theme of One Health, AK INBRE 3 expanded its network in 2017 to
include two Tribal health organizations, the Southcentral Foundation and the Alaska Native Tribal Health
Consortium. AK INBRE 3 led statewide summits for the coordination of relevant curriculum development and
provided support for new and augmented biomedical courses throughout the UA system. AK INBRE 3
supported research experiences for 100 undergraduate students in biomedical laboratories and proposes for
AK INBRE 4 a new partnership with the Alaska Native Science and Engineering Program to increase the
number of Alaska Native students pursuing careers in biomedical and behavioral health research. AK INBRE 3
developed an effective administrative core with capable leadership distributed across its network and
transparent, merit-based mechanisms for distribution of support. It has helpful and committed advisory
committees with national representation. AK INBRE 3 led efforts for the coordination of planning and sharing of
resources with other infrastructure and diversity programs in Alaska with common goals of enhancing the
health of people and communities and promoting workforce development in Alaska and the nation. In a time of
economic stress, the University of Alaska has recruited 29 faculty with programs in biomedical and behavioral
research and is committing substantial institutional support for investing in their development and the retention
of successful investigators achieving independent researcher status through a Sustaining Research Excellence
Core proposed for AK INBRE 4. An award for continuing the INBRE program will be crucial to building on the
initial success of the new partnerships and sustaining the momentum of growth recently seen in biomedical
and behavioral research in Alaska.

Public health relevance
Alaska INBRE 4 – OVERALL NARRATIVE The Alaska IDeA Networks of Biomedical Research Excellence 4 (AK INBRE 4) program invests in growing and enhancing the capacity of biomedical and behavioral health researchers in Alaska for improving the health and well-being of Alaskans and the nation. The program supports increasing and diversifying the pipeline of students seeking careers in biomedical research in Alaska. Through its One Health research theme and focus on health disparities in Alaska Native people, AK INBRE 4 emphasizes the importance of recognizing interconnections among the health of people, animals, and the environment to sustain healthy communities during a time of rapid change in the northern-most state.